Gravida traumatic brain injury (TBI) impacts neurodevelopment of the offspring

PROJECT SUMMARY/ABSTRACT
Intimate partner violence (IPV) increases the risk of traumatic brain injury (TBI), because the physical assaults
target the head, neck, and face. Women, more than men, across socioeconomic, racial, educational, regional,
and other demographic variables are in harm’s way throughout their life and particularly during pregnancy. When
one partner is pregnant, the frequency and intensity of physical assaults increase and remain focused on the
head, neck, and face. But, the consequences of a TBI during pregnancy (gravida TBI; gTBI) on offspring neuro-
development are unknown. Isolated TBI elevates stress and inflammation, which are known to divert fetal neuro-
development with gestational exposure. The proposal goal is to provide proof-of-concept that gTBI can disturb
neurodevelopment, thereby establishing gTBI as an environmental risk factor for developmental disorders.
These studies cannot be performed in people or be derived from existing databases, thereby warranting
laboratory studies. Preliminary data from this research team showed live births, low male weaning weight,
distorted cortical circuity, reduced anxiety and depression, and a muted immune response principally in male
gTBI offspring. These results encourage further investigation of TBI timing with respect to pregnancy, broader
assessment of neuropsychiatric outcomes, enhanced neural circuit analyses, and molecular investigations of
cell and synaptic change. The extent of neurodevelopment disruption is compared to a standard model of
maternal immune activation (MIA) and respective controls. The central hypothesis of this proposal is that TBI
during pregnancy leads to disrupted neurodevelopmental trajectory in the offspring that includes altered
neurobehavioral performance, neurocircuit organization, and cell type-specific molecular disturbances.
To test this hypothesis, a diffuse TBI will be delivered to timed-pregnant mice at 5 and 12 days post-coitum and
then follow male and female offspring in terms of: [Aim 1] birth outcomes, offspring physiology, neurobehavioral
phenotype; [Aim 2] neurocircuitry phenotype, and [Aim 3] synaptic protein expression and cortical cell type-
specific gene expression (transcriptomics). Aim 1 will evaluate early post-natal behaviors; cognition, anxiety,
depressive-like, and sensorimotor gating in young adult; and social behaviors in adult offspring. In Aim 2, cortical
and hippocampal synaptic physiology and cortical connectivity will be evaluated by electrophysiology and laser
scanning photostimulation, and aligned with quantitative neuronal morphology. In Aim 3, western blot
quantification of synaptic proteins and cell type-specific transcriptomics inform circuit development and molecular
trajectories. Impact: Successful completion of the proposed studies will provide the first proof-of-concept that
consequences of TBI during pregnancy, often resulting from IPV, can distort developing brain circuity and
determine a neurodevelopmental disorder behavioral phenotype.

Public health relevance
PROJECT NARRATIVE Intimate partner violence includes assault to the head, neck, and face, with approximately 90% of survivors reporting symptoms concordant with persistent post-concussion symptoms, wherein pregnancy is associated with increased intensity and frequency of physical assault. Like stress, drugs, and inflammation, traumatic brain injury (TBI) during pregnancy can increase the environmental risk for neurodevelopmental disorders in the children. The proposal extends strong proof-of-principle results to explore the outcomes of gravida TBI in mice on the neurobehavioral, neurocircuitry, and molecular phenotypes of offspring to better inform science, education, and policy making.